Synthesis and Study of Medicinally Important Molecule

Project Summary/Abstract
The goal of our research program is to innovate in both the strategy and methodology of organic synthesis,
and apply them to solve problems of biological and medicinal importance and ultimately impact human health.
Our program focuses on synthesis and study of both natural (Project 1A-C) and unnatural (Project 2)
molecules with particular potential for the treatment of cancer, neurological disorders, and drug resistant
infectious diseases. In project 1, we aim to synthesize lyconadin alkaloids (1A), bridged macrolides (1B), and
polycyclic diterpene (1C) natural products and their analogs and identify compounds based on these privileged
scaffolds for novel therapeutic development. In project 2, we aim to develop novel and practical amphoteric
diamination methodologies including the enantioselective versions to provide new avenues toward N-
heterocycles including piperazine, 1,4-diazepane, 1,4-diazocane, and related macrocyclic compounds with
significantly increased substitution diversity on the carbon atoms. The selected natural molecules represent
both the state of the art challenges for complex molecule synthesis as well as potential novel therapeutics for
various human diseases. However, access of these natural products and their analogs are extremely difficult,
which significantly hampered their biomedical development. The N-heterocycles are indispensable structural
motifs in medicinal chemistry and exist in many lifesaving drug molecules. However, the substituents are
generally limited on the nitrogen atoms and there is a significant lack of substitution diversity on the carbon
atoms due to the limitations of the current synthetic methodologies. Our research program will address these
gaps. The expected outcomes of this research will provide (i) new reactions and strategies in the toolbox of
both medicinal chemists and synthetic chemists to prepare functional molecules, (ii) a collection of medicinally
relevant molecules featuring structural novelty, complexity, and diversity for further and larger biological
evaluations in academic institutions and pharmaceutical industries, and (iii) novel anticancer, anti-
neurodegenerative and antimicrobial lead compounds with potentially novel mode of actions for in vivo and
clinical evaluations.

Public health relevance
PROJECT NARRATIVE The proposed research aims to establish general and flexible synthetic approaches and methodologies to enable access of bioactive natural products and medicinally important N-heterocycles, which are otherwise very difficult to acquire due to their scarcity, structural complexity, and high cost. This research will also open new avenues toward collections of structurally novel small molecules that incorporate the key structural elements of the selected natural molecules for anticancer, antimicrobial, and anti-neurodegenerative drug discovery. The strategies and methodologies developed in this research will significantly enrich the toolbox of both synthetic chemists and medicinal chemists.